Authentic Literacy and Language (ALL) for Science

PROJECT SUMMARY/ABSTRACT
The Authentic Literacy and Language (ALL) for Science partnership is developing curriculum materials to
authentically engage elementary school students in how scientists use language, while building students’
science knowledge and skills. Building on a previous project with demonstrated results with students in
grades 2-3, ALL for Science is creating four curriculum units for students in grades 4-5 that integrate
standards aligned life science topics, with development of students’ science specific disciplinary
literacies, numeracy and related health content. Science themes for the units focus on areas of low
student performance in life science and reading/writing in Texas.
The project will engage a team of teacher leaders, scientists and educators to develop four Texas
standards- and NGSS- aligned curriculum units, each designed to provide 3–4 weeks of life science
inquiry-based instruction in school or as a blended school and home approach, with aligned
reading/English language arts, health and numeracy. The curriculum units and supporting materials will
be piloted in local classrooms; field tested through well-matched comparison group studies, with random
assignment of groups; and disseminated via the established, high traffic website, BioEd Online
(www.bioedonline.org), and through other pathways to reach state and national audiences with high
quality, free teaching resources. The project directly will impact approximately 285 teachers and 6,840
students, with availability to teachers of more than 800,000 Texas students and national audiences.
The ALL for Science units will be evaluated in urban schools with high enrollments of underrepresented
minority and economically disadvantaged students. In addition, two Houston-area elementary schools
(combined enrollment of more than 1,200 students) will serve as longitudinal implementation sites to
gauge impacts on student achievement and formation of science identity, and teacher practices, while
informing continued project improvement and local dissemination. We will measure changes in teaching
practices and science teaching efficacy beliefs; and will examine growth of students’ content knowledge,
science-specific disciplinary literacies and identity formation as members of a science community.
This project responds to the SEPA program call for innovative curricula that will prepare students in
STEM and enable their teachers to provide instruction using a novel approach. It addresses two of the
three new areas of high programmatic interest: embedded math and reading content and adaptations of
successful SEPA programs with new populations.

Public health relevance
PROJECT NARRATIVE The project provides a novel framework for integrating science inquiry with reading/English language arts (ELA) for students in grades 4-5. The strategies employed are designed to contribute to equitable access by students to high quality science learning experiences that build science identity and persistence in pathways to science careers.